Using genetic variation to study biology of blood lipids & coronary heart disease

Abstract
Mitral valve prolapse (MVP) is a common yet underrecognized condition carrying significant morbidity
and mortality. Current management only includes surveillance and surgery. While genomic character-
ization has emerged as a tool to prioritize targets for medicines and improve risk prediction, such
analyses for MVP are relatively underpowered compared to many cardiovascular traits due to under
recognition. The goal of this administrative supplement is to study the genetics of MVP using a large-
scale genome-wide association study of over 18,000 MVP cases. Our research team combines
strengths in cardiovascular medicine, statistical genetics, and high-throughput genetics and ge-
nomics. In Aim 1, we will develop a natural-language processing-based definition of MVP and MVP
sub-phenotypes to improve case identification. We will then complete a genome-wide association
study of MVP and MVP sub-phenotypes. In Aim 2, we will develop a polygenic risk score framework
to stratify risk of sudden cardiac death among individuals with MVP. This administrative supplement
will leverage the infrastructure we have built through the Global Lipids Genetics Consortium (GLGC)
and our established collaborative relationships. Completion of our aims will provide new insights that
have the potential to catalyze breakthroughs in prevention, treatment, and diagnosis of MVP.

Public health relevance
Narrative Common valvular heart diseases including mitral valve prolapse carry significant morbidity and mor- tality. We propose to perform genetic analysis for mitral valve prolapse in a large number of individu- als and to use polygenic scores to stratify risk of sudden cardiac death among individuals with mitral valve prolapse.